A New Model to Identify Preterm Neonates at High-Risk for Cognitive Impairments and School Readiness

Project Summary/Abstract
Children born very preterm (VPT; <32 weeks’ gestation) face a disproportionate burden of neurodevelopmental
impairments (NDI). Impairments in the subdomains of mathematics, reading, and behavior are the most common
NDI, affecting 25-50% of VPT children. These abilities are critical to school readiness and success at work. In
the first cycle of this grant, we assembled the largest North American cohort of VPT infants and performed
advanced brain MRI at term corrected age (CA) with longitudinal neurodevelopmental assessments. We
demonstrated the clinical importance of diffuse white matter abnormality (DWMA) and multiple other novel MRI
biomarkers to enhance prediction of short-term NDI at 2 or 3 years CA. During this second funding cycle, our
unique cohort will reach the critical early school ages of 5 to 7 years, when higher-order cognitive abilities in
math and reading, emotional self-regulation, and behavior become more apparent and accurately testable. The
ability to accurately predict these functions several years earlier could enable early interventions. Assessment
of the dynamic trajectories of NDI in VPT children and their modifiable environmental and biologic causes can
also accelerate the development of targeted neuroprotective interventions during these critical early years when
neuroplasticity is at its peak. The overall objectives of this proposal are to map the early childhood trajectory of
brain structural and functional changes and develop early and accurate prognostic models of school readiness.
Our rationale is that elucidation of the long-term impact of DWMA, identification of the trajectory and mediators
of NDI changes, and robust prognostic models of school readiness will enable novel early intervention trials in
targeted VPT infants. To achieve our goals, we will perform morphometric, diffusion, and functional MRI at age
5 and comprehensive developmental testing at 5 and 7 years CA in our cohort of VPT children and a matched
group of term-control children. To advance this highly impactful area of research, we propose the following three
specific aims: (1) Determine the impact of DWMA at term CA on brain development and functional impairments
at age 5; (2) Model individual trajectories of NDI and identify the mediators of neurodevelopmental changes
between 3 and 7 years CA; and (3) Develop early prognostic models of school readiness. For the first aim we
will correlate objectively quantified DWMA volume at term CA with brain structural and functional connectivity
derived from advanced MRI and with higher-order cognitive functions, both at 5 years CA. Under Aim 2, we will
plot individual trajectories of neurodevelopmental scores and identify the mediators of trajectory change between
3 and 7 years CA. For the third aim, we will apply the rich collection of clinical, biologic, and neurodevelopmental
data collected between birth and 3 years CA to predict our three measures of school readiness at 5 and 7 years
CA. This study will provide U.S. population-based prevalence data about the long-term adverse neuroanatomic
and functional consequences of VPT birth, identify mediators of NDI change, and facilitate early prediction of
school readiness to enable targeted EI and novel randomized clinical trials for VPT children.

Public health relevance
Project Narrative The proposed research is relevant to public health because we will use advances in brain imaging and machine learning prognostic modeling to considerably reduce time to diagnosis of learning and behavioral problems and subsequent school readiness. This will allow earlier, more targeted interventions, thereby reducing rates of developmental disorders and school failure. The project is relevant to NINDS’ mission because this approach should yield fundamental knowledge about the most common developmental disorders in children born very preterm.